Using Mobile Technology to Reduce Stress in Caregivers of Persons with Dementia. A Scalable Solution to A Growing Problem

PROJECT SUMMARY:
Using the NIA 2 year R21 grant mechanisms, the proposed study will examine the feasibility (markers of acceptability
and demand), and proof of concept of the consumer based mobile mindfulness application Calm in decreasing stress,
emotional distress and sleep dysfunction in heterogeneous, geographically diverse, stress caregivers of individuals with
ADRD. Calm teaches fundamentals of mindfulness and uses evidence based behavioral principles to engage caregivers in
sustained practice (>10 min/day) with minimal time commitment, when it is convenient for them, without the need of
travel or of a trained provider. To achieve our aims, we will conduct a single blind, pilot, feasibility, proof of concept
RCT of CALM (12 weeks, > 10 minutes daily practice) versus an attention placebo time and dose matched podcast
control (POD; 12 weeks, >10 minutes daily listening). Assessments will be conducted at baseline, post program (12 weeks
later) and at 20 weeks follow-up. Caregivers will also complete weekly assessments. Our team is well positioned to
conduct this study with specific experience with mobile applications including Calm; intervention development,
feasibility testing and clinical trials; ADRD caregivers; recruitment of national, geographically diverse samples; R21 grant
proposals. At the end of the 2-year period of this R21 we will have clear evidence of the feasibility of study procedures,
randomization, acceptability, credibility, adherence, ability to retain and recruit as well as its proof of concepts in reducing
stress in caregivers of people with ADRD. Results from this R21 study will be used to apply for funding to conduct a fully
powered efficacy RCT, if set benchmarks are met (see Table in the Research Strategy), through an R01. The goal is
dissemination and implementation of Calm to reduce stress, emotional dysfunction, and sleep difficulties among all
caregivers of individuals with ADRD.

Public health relevance
PROJECT NARRATIVE: By reducing stress in caregivers of ADRD, the proposed work has the potential to drastically improve emotional and physical health in not only caregivers, but also the people they care for. Calm teaches meditation, an evidence-based stress reduction technique without the burden associated with traditional in person or virtual meditation-based interventions. As such, there is tremendous opportunity for scalability and improved care for ADRD caregivers across the world.